Cancer Genetics Professional Education in a Global Community of Practice

Technological and therapeutic advances have generated an unprecedented infusion of genomic information
into clinical practice, further fueling the need for a skilled workforce to navigate genomically-informed patient
care. There is a continued gap between the need for, and availability of, skilled genomic cancer risk
assessment (GCRA) clinicians. This R25 project continues the mission of the Clinical Cancer Genomics
and Community of Practice (CCGCoP) to help address the ongoing need for clinicians competent in
evidence-based cancer genomics care. The CCGCoP uses the theoretical framework of situated learning, the
resources and expertise of the academic cancer center, and a distinguished faculty of widely-recognized
thought leaders in a multimodal inter-professional course in GCRA for clinicians practicing in diverse
communities with limited access to GCRA services. With R25 support, the CCGCoP has attained international
recognition as a standard-bearer in GCRA professional education, facilitating improved patient access to
GCRA services. The CCGCoP alumni represent a uniquely qualified community of clinicians across all 50
states and 32 countries. Since initiation of this continuation project period (09/20/2018 to present) the course
has been successfully completed by 565 clinicians from diverse training backgrounds and practice settings.
The course is delivered through a hybrid two-track model that combines distance didactics, web conferencing,
and face-to-face professional development workshops. The stated aims for the continuation renewal award
period (09/20/2018 through 08/31/2023) are: 1) Continue the established CCGCoP intensive course; 2) Review
and update course curriculum, and map content to inter-professional GCRA competencies; 3) Evolve the
collaborative learning portal and add additional academic GCRA case conference forums; 4) Update course
assessment instruments and develop new competencies-based diagnostics to assess learning and impact on
patient-centered outcomes. The scope of these aims remains the same. However, to prevent disruptions
associated with the global COVID-19 pandemic and preserve the integrity of the course experience and
learning outcomes, we had to convert the face-to-face workshop component of the course to a virtual delivery
format. To accomplish this conversion we developed an online platform to support real-time interactive virtual
workshops for skills and professional development activities. We submit this administrative supplement to
request support to cover the costs incurred to make this conversion.

Public health relevance
Project Narrative To help address the significant global demand for cancer genomics education, skills development and evidence-based patient care, this project continues a widely-recognized hybrid Intensive Course and Clinical Cancer Genomics Community of Practice for community clinicians. The project works from the theoretical framework of situated learning and leverages the resources and expertise of the City of Hope and other academic centers to promote genetic cancer risk assessment skills development for community-based clinicians. This administrative supplement is submitted to fund costs associated with converting the essential face-to-face workshops in the course to a virtual delivery format to avoid disruptions due to the global COVID- 19 pandemic.